Effect of baseline and intercurrent medical factors on 6-year cognitive trajectory: Secondary analysis of the SAGES Study

Responding to PAS-19-391, this proposal will leverage existing data to advance our understanding of
Alzheimer’s disease and related dementias (AD/ADRD) and to nurture the career of a promising early stage
investigator, Dr. Tammy Hshieh. This proposal will use data drawn from a clinically rich cohort, the Successful
Aging after Elective Surgery (SAGES), involving 560 older adults (age 70+) without clinical dementia evaluated
prior to major elective surgery and followed for 6 years with repeated neuropsychological testing. We plan to
explore a priority area in the PA: ‘to advance our understanding of how cognitive function may change from
normal to pathological cognitive aging’, which we here define broadly as including both AD- and ADRD-related
processes. SAGES has collected data on intercurrent illnesses, hospitalizations, surgeries, and major
treatments (e.g., chemotherapy, hemodialysis) for up to 6 years. We propose to evaluate the effects of these
intercurrent factors on cognitive trajectory, along with the moderating effects of delirium and/or ApoE-E4 status,
which may serve as markers of brain vulnerability.
Our specific aims are: (1) To evaluate the effect of intercurrent medical factors on cognitive trajectory for up
to 6 years: We will examine factors first singly then cumulatively with the hypothesis that certain factors will
have greater decrements considered singly and that a higher number of factors will result in a steeper slope of
decline over time, achieving rates of decline comparable to MCI or early AD/ADRD. (2) To examine the effect
of abnormal baseline laboratory results and inflammatory biomarkers (e.g., C-reactive protein, interleukin-6) on
cognitive trajectory: We hypothesize that a higher number of abnormal laboratory values and/or biomarkers will
have a highest rate of cognitive decline, achieving rates of decline comparable to MCI or early AD/ADRD. (3)
To elucidate whether development of delirium and/or genetic risk (ApoE-E4 status) moderates the association
of major intercurrent factors or abnormal laboratory- or bio- markers, either singly or cumulatively, on cognitive
trajectory. Our analyses will utilize an innovative longitudinal data analysis approach with time-varying
predictors to generate a weighting algorithm for a dynamic index (an index that can change within a person
over time), representing the cumulative effect of potential cognitive insults. We have demonstrated adequate
statistical power to achieve our aims. Success of the proposed work is further assured by a highly skilled
interdisciplinary team who have been close collaborators for over 10 years, and who will mentor Dr. Hshieh.
This project will help to identify intercurrent factors or abnormal laboratory- or bio- markers that may lead to
cognitive decline, particularly in those individuals with more vulnerable brains, as signaled by ApoE-E4 or by
development of delirium. Understanding these factors will help us to identify potential pathways which might
transform normal to pathological cognitive aging. Such understanding will advance our pathophysiologic
understanding, and lay the groundwork for future targeted intervention strategies.

Public health relevance
Narrative Delirium is a disorder with acute confusion that has strong connections to cognitive decline and Alzheimer’s Disease and Related Dementias (AD/ADRD), yet the relationship of delirium to risk factors and medical events such as surgery along the course of cognitive decline is not well understood. For this study, we will examine patients undergoing major surgery to determine how medical events, abnormal laboratory and biomarkers and genetic risk (APOE-E4 status) correlate with delirium and worsened cognitive function for up to 6 years. Better understanding of how delirium and risk factors impact patients’ cognitive trajectory will advance our understanding of pathological cognitive aging and pathways to AD/ADRD.